Identifying and Targeting Metabolic Dependencies in the Pancreatic Tumor Microenvironment

PROJECT SUMMARY/ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) cells maintain proliferative capacity despite a hypovascular, nutrient-
poor microenvironment; this challenging microenvironment is established by cancer-associated fibroblasts
(CAFs). PDAC CAFs are predominantly derived from pancreatic stellate cells (PSCs), lipid-storing cells in healthy
pancreas which can transdifferentiate to an activated CAF phenotype and generate a dense, desmoplastic
stroma. CAF-derived components generate an oxygen- and nutrient-poor microenvironment to which PDAC cells
must adapt. These adaptation mechanisms remain poorly understood, and may represent vulnerabilities for
therapeutic intervention. Our recent results suggest that paracrine lipid flux from PSC-derived CAFs represents
a novel mechanism by which the stroma provides energy and pro-proliferative signals to cancer cells to support
PDAC growth. Specifically, we find that PDAC CAFs secrete abundant lysophosphatidylcholine (LPC), the
preferred fatty acid scavenging substrate for Ras-transformed cells such as PDAC cells; the PDAC CAF
secretome also contains high levels of lysophosphatidic acid (LPA), an established mitogen with multiple
downstream effectors with roles in tumorigenesis. Our preliminary transcriptional and lipidomic data suggest that
PSCs undergo a dramatic lipid metabolic shift in the context of pancreatic tumorigenesis, including remodeling
of the intracellular lipidome and secretion of abundant lipids in the activated CAF state. These results raise the
possibility that PDAC CAFs secrete specific lipid species that act in a paracrine manner to “feed” the epithelial
compartment and stimulate proliferation. We hypothesize that fibroblastic cells function via secreted lipids to
promote epithelial cell proliferation and survival in the context of an inhospitable wound-healing response. This
hypothesis will be tested with the following specific aims. Aim 1: Understand the effect of stroma-derived
lipids on cancer cell lipid metabolism. A stable isotope tracing approach will be used to determine the extent
of paracrine metabolic flux from stromal cells to cancer cells among secreted lipids, and alterations to PDAC cell
metabolism in response to stroma-derived lipids will be assessed using established metabolic assays. Aim 2:
Determine the role of stroma-derived lipids in PDAC cell growth control. Established in vitro culture and
co-culture systems will be used to analyze regulation of mitogenic LPA effectors pathways and growth capacity
in response to stroma-derived lipids. Aim 3: Define the significance of the LPC-Autotaxin-LPA axis in
microenvironmental regulation of pancreatic cancer growth in vivo. LPA is generated from LPC by secreted
enzyme Autotaxin; we find that LPC is secreted at high levels by PDAC CAFs, and that ATX is overexpressed
in mouse and human PDAC. The LPC-Autotaxin-LPA axis will be interrogated both genetically and
pharmacologically in a PDAC mouse model in vivo to determine its role in PDAC progression. These studies will
improve our understanding of PDAC cell survival and growth mechanisms in the context of a nutrient-poor tumor
microenvironment, potentially identifying a novel route for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Understanding how pancreatic cancer cells continue to grow and adapt in the context of a nutrient-poor, challenging microenvironment would help to identify potential strategies for therapeutic intervention. The studies proposed here will examine the novel hypothesis that particular cells within pancreatic tumors known as stellate cells have evolved mechanisms to “feed” energy to cancer cells to simultaneously promote their survival and growth, and to regulate expression of cancer-supportive genes. Together, these studies will help us understand the unique metabolic properties of pancreatic cancer cells, and may identify a novel metabolic liability of pancreatic cancer to be targeted for therapeutic benefit.